ENERGY BALANCE AND METABOLISM IN NONINSULIN DEPENDENT DIABETES MELLITUS

The goals are to establish the underlying metabolic abnormalities responsible for increased hepatic glucose production and triglyceride production in NIDDM and to determine the effects of short-term dietary energy restriction vs. changes in body composition on those underlying abnormalities.